RLIP, Mitochondrial Dysfunction in Alzheimer’s Disease

PROJECT SUMMARY
Alzheimer's disease (AD) is a neurodegenerative disorder that affects a large proportion of the aging
population. Despite its prevalence, no specific treatments can prevent or treat this disease. Research on the
pathophysiology of the disease and the testing of new drugs is limited to transgenic mouse models harboring
mutated versions of AD-related genes, including APP, PSEN1, APOEɛ4, and ob (leptin). Since oxidative
stress (OS) in the brain is believed to be involved in AD pathogenesis, markers of OS such as protein
oxidation, lipid oxidation, DNA oxidation, glycoxidation, and mitochondrial dysfunction may also have utility as
markers for AD. RalBP1 (Rlip) is a stress-activated protein that plays a crucial role in OS defense as the rate-
determining enzyme in the efflux of the GSH-conjugated oxidative metabolites. While we have extensively
characterized the role of Rlip as a centrally important oxidative stress-defense mechanism in the etiologies of
cancer, metabolic syndrome, and diabetes, we have only recently begun to study its function in neurons. Our
preliminary data and published suggests that the Rlip knockout in neuronal cells and Rlip mice developed
strong mechanistic links with oxidative stress/mitochondrial dysfunction and synaptic damage in AD. Further,
Rlip deficient mice and neurons have increased OS in the brain and downregulation of NRF2, which OS
normally up-regulates. This dysregulated NRF2 response likely contributes to further exacerbated oxidative
stress, impaired xenobiotic metabolism, and dysregulated mitochondrial functions in these mice. We provide
intriguing preliminary evidence of Rlip deficiency in human postmortem AD brains and abnormalities of
mitochondrial structure, function, and proteins in Rlip deficient mice and in Rlip deficient neurons in culture.
Our preliminary studies show that Rlip depletion epigenetically regulates several AD-linked genes, including
CREBBP, a gene implicated in neurocognition. The Rlip+/- model will allow us to develop an oxidative stress
animal model of AD, which in turn will be helpful in the development of drugs for the treatment of AD and in
conducting studies that will lead to novel findings on AD biology. Based on our preliminary findings, we
hypothesize that Rlip deficiency causes oxidative stress, which exacerbates neurodegeneration and
dysregulation of neurocognitive functions; therefore, reducing oxidative stress signaling through Rlip
upregulation may improve mitochondrial and synaptic functions and cognitive behavior. Under the proposed
Aims 1) we will study whether Rlip knockout mice have neurocognitive, histopathological, biochemical, and
neuronal deficits resembling those seen in humanized Aβ knock-in (hAβ-KI) mice, and 2) whether Rlip
upregulation ameliorates the phenotypic severity of the hAβ-KI model. These studies will offer novel insights
into the regulation of oxidative stress defenses in AD and may lead to new treatments for AD.

Public health relevance
PROJECT NARRATIVE The long-term goal of our research is to understand the role of Rlip in oxidative stress/mitochondrial dysfunction and synaptic damage in Alzheimer’s disease (AD) pathogenesis. Our extensive preliminary data based on postmortem AD brains, AD neurons and Rlip deficient mice provide a strong premise and further warrant proposed investigations. We propose to study whether 1) Rlip overexpress reduce oxidative stress signaling and improve mitochondrial and synaptic functions, and 2) reduced Rlip cause further damage to neurons via mitochondrial dysfunction, synaptic damage and increase cognitive dysfunction in AD.